ASM MOSAIC Program

The American Society for Microbiology’s Maximizing Opportunities for Scientific and Academic Independent Careers (ASM MOSAIC) program is a five-year initiative that will support early-career scientists to transition successfully from postdoctoral positions to tenure-track faculty positions at research-intensive institutions. ASM MOSAIC’s three phases will cover the skills needed to (1) secure a faculty position at a research-intensive university, (2) excel in a faculty position, and (3) become a scientific leader. All three phases will include courses and workshops for skill development and mentoring. The program’s first specific aim focuses on the foundational skills required to gain faculty positions. To address this aim, the program will pair each scholar with a network of mentors to help them assess different career pathways, develop the skills needed to maximize their productivity as a postdoctoral fellow, and transition to a faculty position. The mentors will consist of (i) an institutional mentor, (ii) a scientific mentor, and (iii) a career development mentor. The second specific aim will help the scholars embark on a successful tenure-track career and will cover setting goals, building relationships with department leadership, establishing a research laboratory, and managing work-life balance. The scholars will also take grant and manuscript writing courses and participate in mentorship training. The third specific aim focuses on catalyzing the scholars’ progression to scientific leadership. This phase of the program will provide the scholars with the skills to acquire sustained research funding, build a scientific reputation and professional network, and understand the business of science. To grow their networks, the scholars will attend ASM conferences. The ASM MOSAIC program will support early career scientists to achieve successful careers as microbiologists and immunologists and prepare them to mentor the next generation of scientists.

Public health relevance
This joint initiative from ASM and NIH MOSAIC will contribute to increasing the number of faculty in the microbial sciences, making the field richer in scientific discoveries. Microbiology research involves understanding basic life processes and promoting knowledge gained for improved public health as well as economic and environmental well-being. The faculty in microbiology will represent a broad spectrum of subdisciplines and contribute to mentoring the next generation of scientists.